NMR Research Core Facility

The NMR Research Core Facility consulted on many projects in FY2021. The following investigators utilized the facilities.

Paul Doetsch: The NMR core provided metabolomic analyses of yeast extracts and experimented with glutathione radical chemistry.
Traci Hall: RNA structures were determined, and the binding of proteins were localized to structural features on the RNA structure.
Jason Watts: The NMR core examined nucleotide samples for evidence of G quadruplex formation.
Gaylia Jean Harry: Metabolomic samples of mouse brain extracts were characterized.
Suchitra Kaveri Hourigan: Fecal samples from leukemia survivors were characterized.
Cynthia Vanessa Rider: Botanical extracts were characterized.
Jason Alexander Wallits: Fecal samples from patients with chronic fatigue syndrome were characterized for metabolites present.
Rachel Caspi: Cecum and fecal samples from mice were characterized for various metabolites.
Stavros Garantziotis: Protein samples were tested for binding to hyaluoronic acid.
Paul Wade: NMR samples of histone proteins were prepared with stable isotopes.
Lars Pedersen: Protein samples were characterized for folded state.
Shyamal Peddada: Human saliva samples were characterized for metabolite comparisons.
Robin Stanley: RNA samples were analyzed for nucleotide orientation.